ADMINISTRATIVE CORE

The Administrative Core (Core B) will coordinate communication and sharing of research resources related to the Program Project. The Administrative Core will be responsible for the following activities: 1. Monitoring the progress of all Projects. 2. Coordinating the submission of our non-competitive renewal application. 3. Organizing the 3 site visits by the External Review Committee. 4. Coordinating visits of the Principal Investigators every six months. 5. Coordinating monthly PI and lab member teleconference meetings between PI visits. 6. Maintain oversight of the overall and individual budgets and resolve budgetary issues that may arise during the funding period. 7. Facilitate the patient participation in the clinical studies and in obtaining biopsy and autopsy tissue.

Public health relevance
Core B will provide administrative support required for all components of this Program Project. The coordination of tissue sample distribution between Projects which provide an invaluable research resource. The coordination of video conferences and reviews of the project will help ensure that the appropriate progress is made by each Project, that the research remains focused on the major objectives of the Program and that maximum efforts are maintained to move the research forward.